Maternal Resilience to Stress, Neonatal Outcomes, and Racial/Ethnic Health Disparities

PROJECT SUMMARY
Training: The purpose of this K23 proposal is to prepare Dr. Diana Montoya-Williams for a career as an
independent clinician scientist. Her long-term career objectives are to contribute to the development of
policies and interventions that diminish health disparities among pregnant minority women and their infants.
Her immediate goal is to obtain the knowledge and skills to complete rigorous longitudinal studies of
maternal-infant dyads aimed at defining assets that protect women against adverse neonatal outcomes. To
meet these goals, Dr. Montoya-Williams and her mentor team have devised a career development plan
that integrates: 1) intensive mentorship from successful investigators; 2) focused training in longitudinal
cohort and statistical path analyses; and 3) innovative research on the relationship between resilience,
stress and adverse neonatal outcome disparities.
Research: Significant racial, ethnic and nativity-related disparities exist for birth weight, gestational length
and breastfeeding in the U.S. and have major implications for our elevated infant mortality rates. Maternal
psychosocial stress has been linked to these adverse neonatal outcomes and is disproportionately
experienced by minority women. Resilience is the ability to respond to stress and appears to change in the
face of stressors. Higher resilience has been linked to improved outcomes in conditions like diabetes and
cardiovascular disease; there is also evidence that resilience can be improved. However, our knowledge of
resilience in pregnancy is scarce and a major limitation is the cross-sectional nature of existing data. It is
not clear whether resilience changes through the course of pregnancy and whether it modifies the
relationship that exists between maternal stress and adverse neonatal outcomes. In addition, resilience
may vary by race, ethnicity and nativity but data is limited. Dr. Montoya-Williams’ mentored research will
address these key knowledge gaps. By creating a diverse longitudinal cohort of pregnant women, she will:
1) explore the association between resilience, three different types of perceived self-reported stress (acute,
intermediate chronic and remote traumatic) and the physiologic manifestations of stress (i.e. allostatic load)
at the onset of pregnancy; 2) describe whether resilience measured repeatedly in pregnancy changes in
response to acute pregnancy-related stressors; and 3) investigate associations between the trajectory of
resilience in pregnancy and adverse neonatal outcomes. Importantly, she will describe any differences that
may exist in these relationships for women of different ethnoracial and cultural backgrounds.
Summary: Findings from this study will inform an R01 proposal to test resilience interventions that may
mitigate the stress-related drivers of neonatal health disparities. Through this award, Dr. Montoya-Williams
will also emerge as a leading independent clinician scientist contributing to the amelioration of neonatal
racial/ethnic health disparities.

Public health relevance
PROJECT NARRATIVE Neonatal outcome disparities by maternal race, ethnicity and place of birth are persistent and have complex roots that include differential maternal experiences of stress. This project seeks to explore the longitudinal trajectory of resilience (or the ability to respond to stress) during pregnancy as well as any resilience differences that might exist by women’s race, ethnicity, nativity and level of acculturation. By preparing the applicant for a career in longitudinal cohort research and examining the impact of resilience on the relationship between stress and neonatal outcome disparities, this proposal will provide critical foundational knowledge for the development of interventions to build resilience and diminish the risk of poor neonatal outcomes among pregnant minority women and their infants.